Research Infrastructure for Demographic and Behavioral Population Science Dissemination Core

The objectives of the Dissemination Core are to deliver relevant, high quality ready-to-use datasets and data to external researchers, to translate data and research findings for a range of audiences, and to share knowledge and expertise about publication and dissemination of research to researchers outside of the Institute.